ROLE OF GI PHOSPHOLIPIDS IN ULCER PROTECTION

The mechanism by which the stomach protects itself from autodigestion by the acid contained within its lumen has not been elucidated to date. In this proposal we outline a series of experiments to investigate the role of intrinsic and extrinsic surface-active phospholipids in this protective mechanism. These studies developed from preliminary findings from our laboratory which indicated that: 1) amphoteric phospholipids present in pulmonary surfactant have the capability of increasing the hydrophobic (non-wettable) property of inert and biological surfaces; 2) these same surface-active molecules are present in the gastric juice and mucosal lining; 3) the intact gastric mucosal lining is highly hydrophobic whereas it is rapidly converted to a wettable surface after the stomach is exposed to the barrier breakers, aspirin and bile acid; and 4) acid-induced ulcerogensis and bleeding are markedly reduced if rats are pretreated with an liposomal suspension of extrinsic surface-active phospholipids. It is our contention that these surface-active phospholipids are adsorbed onto the surface of the gastric mucosal surface and in doing so form and non-wettable hydrophobic layer between the acidic luminal contents and the gastric epithelium. In the proposed studies we plan to test this hypothesis by investigating: 1) the relationship between surface hydrophobicity and the integrity of the "Gastric Mucosal Barrier"; 2) the localization of the intrinsic surface-active phospholipids within the gastric mucosa and their cell of origin; 3) the ability of extrinsic phospholipids to protect against contrasting forms of experimentally-induced gastric and duodenal ulcer and 4) the possible mediator role of intrinsic surface-active phospholipids in prostagladin-induced cytoprotection. The latter possibility seems particularly appealing since we have obtained preliminary evidence that prostaglandins acutely stimulate the concentration of surface-active phospholipids within the rodent gastric mucosa.